6th Annual MAC (Midwest Aging Consortium) Aging Research Symposium

ABSTRACT
This application requests partial funding for the 2025 Symposium of the Midwest Aging Consortium
(MAC). The conference will be held April 23-25, 2025, at the Hilton Rochester Mayo Clinic Area Hotel in
Rochester, MN.
The expected attendance is 150-200, including basic scientists, physician-scientists, clinicians, and
other health professionals. Speakers and attendees will integrate junior and senior investigators and
trainees specializing in various scientific disciplines (cell biology, cancer, genetics, medicine, and
geriatrics). This conference represents the 6th annual MAC meeting with a unique blend of cutting-edge
science in the field of aging. The specific topics to be covered at this conference include:
(1) Cellular Senescence and Aging;
(2) Age-Related Disease;
(3) Metabolism and Aging;
(4) Immune Aging;
(5) Clinical Research and Aging;
(6) Stress Response and Aging.
We believe that this meeting is unique, timely, and significant because it will bring together recognized
experts from more than ten institutions in the Midwest, including the Mayo Clinic, University of Wisconsin,
Minnesota, Michigan, Iowa, Indiana, Northwestern, North Dakota, Ohio State, and Illinois-Chicago, which
are all leading institutions in aging, cell biology, genetics, and geriatrics. This 6th MAC symposium is
designed to disseminate new information and promote the interaction between established and junior
investigators. This meeting will provide a framework for novel approaches and future age-related disease
research directions.

Public health relevance
NARRATIVE This application requests partial funding for the 2025 6th Symposium of the Midwest Aging Consortium (MAC) to be held on April 23-25, 2025, at the Hilton Mayo Clinic Area Hotel in Rochester, MN. The MAC symposium brings together top scientists from multiple disciplines and institutions to advance research on aging while striving for an inclusive meeting that actively involves junior scientists.